The Big Ten Electronic Health Record Consortium (Big Ten-EHRC)

Project Summary/Abstract The goal of this application is to create a consortium of Cancer Centers that will communicate and coordinate with the NCI and with electronic health record (EHR) vendors to facilitate and harmonize rapid implementation of EHR investigative treatment plans and related clinical decision support (CDS) for the conduct of NCTN clinical trials. Specific AIMS include: Aim 1. To analyze similarities and differences of research EHR treatment plan and related clinical CDS implementation across Big Ten Cancer Research Consortium (BTCRC) institutions, identifying opportunities for improved efficiency and informing the design of a software-based EHR toolkit to speed such implementation. Aim 2. To develop and implement a novel software-based EHR toolkit that speeds activation of NCTN clinical trials by facilitating single-instance EHR treatment plan development and related CDS. Aim 3. To prospectively determine the effect of the developed software-based EHR toolkit on time required to activate NCTN clinical trials, determine user satisfaction with the toolkit, explore software toolkit dissemination opportunities with NCI and EHR vendors, and promote use of the toolkit through presentation and publication.

Public health relevance
Narrative The Big Ten Electronic Health Record Consortium (Big Ten-EHRC) is ideally suited “to develop processes across multiple NCI-supported Cancer Centers and community sites that will facilitate the development of single instances EHR clinical trial treatment plans”. The Big Ten-EHRC will use the established Big Ten Cancer Research Consortium (BTCRC) partnership to complete this project.